The role of senescence marker p16ink4a in alveolar epithelial stem cells during injury-triggered differentiation

PROJECT SUMMARY/ABSTRACT
The delicate lung alveolus relies on endogenous progenitor cells to maintain its function and regenerate after
repeated insults. The alveolar epithelium contains alveolar type 2 cells (AT2s), which act as stem cells capable
of self-renewal and differentiation into alveolar type 1 cells (AT1s), which cover the alveolus to facilitate gas
exchange. AT2 to AT1 differentiation is a highly regulated process dictated by internal and external cues. Single-
cell RNA sequencing has identified a “transitional AT2” on this differentiation trajectory, marked by Keratin 8 and
senescence proteins like p16. In models of resolving lung injury, transitional AT2s gradually disappear as they
differentiate into AT1s. However, in Idiopathic Pulmonary Fibrosis (IPF) or severe bleomycin (BLM)-induced
pulmonary fibrosis, transitional AT2s persist and are thought to drive the disease. IPF is a devastating
progressive age-related lung disease with no cure, and anti-fibrotic medications do not reverse fibrosis,
suggesting another mechanism underlies IPF pathogenesis. Using a highly sensitive validated mouse p16
reporter developed in our laboratory, preliminary data show that p16 is rarely expressed in AT2s at steady state
but increases in a subset of AT2s and their derivatives after BLM-induced lung injury. I will use a multi-transgenic
mouse model of pulmonary fibrosis to determine the fate of p16-expressing AT2s in vivo and in vitro. Using a
conditional knock-out of p16 in AT2s, I will test the functional role of p16 in AT2s during injury and repair. My
hypothesis is that p16 has no effect on AT2s during homeostasis, but p16 is required for AT2s to enter a
profibrotic state and during injury-triggered differentiation. Furthermore, I predict that AT2-specific loss of p16
will ameliorate the fibrotic phenotype in a BLM-induced mouse model. This research will demonstrate how
manipulating senescence pathways affects AT2 stem cell function and could lead to new therapeutic targets to
reverse pulmonary fibrosis. This proposal is part of a comprehensive training plan built with my mentors to
develop the skills and knowledge needed to become a successful independent investigator in lung regeneration
with an emphasis on chronic and age-related lung diseases. I have assembled a Career Development
Committee composed of physician-scientists and basic scientists from pulmonology and aging who will serve as
both scientific and career advisors. Upon completing this training plan, with support from my team and UCSF's
strong research environment, I will be well-positioned to launch my career in regenerative medicine and
contribute to understanding chronic lung diseases.

Public health relevance
PROJECT NARRATIVE Idiopathic pulmonary fibrosis (IPF) is a devastating and progressive age-related lung disease with a median survival of 2-5 years and no current therapies to reverse the underlying fibrosis. Mounting evidence suggests pulmonary fibrosis is driven by the accumulation of dysfunctional alveolar type 2 cells (AT2s) which fail to terminally differentiate into alveolar type 1 cells and express the senescence markers like protein p16. I will determine the functional role of p16 in AT2s during injury-triggered differentiation using in vivo and in vitro systems which could identify novel mechanisms for manipulating AT2 cells for lung regeneration.